Engineered Models of Diseased Heart Valves to Study Sex Bias in Disease Progression

PROJECT SUMMARY
Calcific aortic valve disease (CAVD) is a prevalent condition for which the only approved treatment is surgical
valve replacement. Age and male sex are the dominant risk factors for developing this disease, which is
characterized in its earliest stages by a change in extracellular matrix (ECM) composition. Moreover, recent
evidence has indicated that the pathogenesis of CAVD in men may differ from that in women.
We hypothesize that male and female valvular cells exhibit differential responsiveness to their
microenvironment (i.e., ECM) and pathological cues (i.e., co-morbidities or risk factors), resulting in divergent
disease trajectories for men and women. While clinical and animal studies can provide snapshots of disease
progression, they do not permit the tailorability and high throughput needed to investigate this question and
precisely monitor the specific cell/microenvironment/stimulus interactions that may yield mechanistic
information about disease progression. Thus, we propose to develop in vitro disease-mimicking environments.
Specifically, we will use novel tissue engineering and ECM-editing methods to create 3D engineered
environments that recapitulate key features of the valve ECM and valvular interstitial cell phenotype at various
stages of CAVD, and then use these scaffolds/tissues to examine disease progression upon exposure to risk
factors and pathological stimuli. These defined, controlled environments will enable hypothesis testing that is
impossible in humans and very difficult or not practical in animals, and will allow a prospective etiological
investigation of sex bias in events that contribute to CAVD through execution of the following Aims:
Aim 1: Construct engineered models that represent the valve microenvironment at different stages of disease.
Aim 2: Investigate sex bias in the onset of inflammation using engineered models of CAVD.
Aim 3: Investigate sex bias in the progression of fibrosis using engineered models of CAVD.
Aim 4: Design organ cultures to validate engineered disease models and probe mechanism.
This work has the potential to identify specific valve changes that can inform the design of sex- or stage-
specific intervention strategies to reduce CAVD risk or progression and sets the stage for future work to
improve CAVD prevention and treatment. We will make these advancements through our implementation of
transformative approaches and tools to study ECM (patho)biology, which can also be readily applied to other
cardiovascular (or non-cardiovascular tissues).

Public health relevance
PROJECT NARRATIVE Calcific aortic valve disease (CAVD) is a prevalent disease with no current treatment options other than surgical valve replacement. One factor that contributes to the lack of treatments is our relatively poor understanding of the cellular- and molecular-level events that drive disease progression. Thus, in the proposed work, we aim to develop engineered in vitro platforms that mimic early valve disease and important physiological stimuli present in the disease environment. These engineered environments will allow us to examine many combinations of variables and probe precise biological questions about potential disease mechanisms. The long-term impacts of this work could be improved prevention and treatment of CAVD.